Integrating multi-omics data to understand the heterogeneity of preeclampsia and long-termpostpartum hypertension

PROJECT SUMMARY
Preeclampsia (PE) is a pregnancy-specific syndrome of progressive vascular dysfunction that leads to escalating
hypertension and extensive maternal organ damage, which can ultimately result in death. Occurring in 5-8% of
pregnancies worldwide, PE is a leading cause of both maternal and perinatal mortality. Beyond the short-term
risks, PE survivors suffer a 2-6-fold increase in lifelong risk of future hypertension (HTN), heart failure, stroke,
and cardiovascular (CV)-specific mortality. Despite its high incidence, the underlying genetic and environmental
contributions to PE is lacking.
Recent advances now allow for the simultaneous analysis of multiple types of omics data (“multi-omics”), offering
new opportunities to identify risk factors for PE and its long-term CV effects. In this project, we will use TOPMed-
supported omics data from the Nulliparous Pregnancy Outcomes Study: Monitoring Mothers-to-be Heart Health
Study (nuMoM2b-HHS) as well as supplementary data from its parent study, nuMoM2b. Both cohorts possess
extensive phenotyping variables. These variables were collected in a standardized manner throughout the
course of pregnancy and the postpartum period, providing an unparalleled level of depth in a large cohort with
long-term follow-up. The nuMoM2b and nuMoM2b-HHS cohorts, with their diverse sample types, large cohort
size, comprehensive clinical and psychosocial phenotyping, and long-term CV follow-up, provide an unparalleled
platform for a holistic analysis of the factors contributing to the increasing burden of CV morbidity associated
with PE.
The long-term goal of our study is to identify risk variants, gene targets and pathways for PE and its associated
long-term CV effects. Our current objective is to perform a first-time analysis of whole genome sequencing (WGS)
data in the nuMoM2b-HHS cohort together with an integrated analysis of multidimensional data from the
nuMoM2b-HHS cohort. To achieve our objective, we propose the following aims. Aim 1: Determine the genetic
architecture of PE (and its long-term CV effects) and gene environment interactions. Aim 2: Determine the role
of placental trophoblast gene expression in the development of PE and long-term CV effects and perform in-
depth multi-omics data integration to provide molecular insights into PE. Aim 3: Optimize predictive models for
PE (and long-term CV effects) through machine learning and integration of clinical, environmental, and multi-
omics data. Completion of these aims will provide one of the most comprehensive models of PE to date, that
integrates data from both the maternal cardiovascular system and placenta-fetal interface. This work will lay the
groundwork for further investigation of the reproductive origins of PE, CV morbidity and health across the lifespan.

Public health relevance
Project Narrative Public Health Relevance Statement: Preeclampsia is a significant pregnancy-related condition that results in vascular dysfunction and hypertension, affecting 5-8% of global pregnancies and causing considerable maternal and perinatal mortality. Beyond short- term risks, preeclampsia survivors face increased long-term risk of hypertension. Our research aims to identify genetic markers and regulatory mechanisms related to these conditions, explore the role of placental gene expression, and develop predictive models for disease onset and severity.